Mechanisms, Structures and Engineering of Flavonoid-producing Dioxygenase Enzymes

ABSTRACT
The overall objective of this research is to fill in the gaps that exist in our structural and mechanistic
understandings of alpha ketoglutarate-dependent dioxygenases, a medically important family of enzymes that
perform a broad repertoire of biochemical transformations. The flavonoid biosynthetic pathway is dependent
upon Flavanone Synthase 1 (FLS1) and Flavanone 3-Hydroxylase (F3H) to make medically significant products,
quercetin and (2S,3R)-trans-taxifolin, respectively. These products have demonstrated health benefits and are
broadly studied to better understand their cellular and metabolic roles in maintaining human health and the health
of the gut microbiome. However, the mechanistic and structural understanding of the enzymes that make these
key flavonoids is incomplete. A stronger biochemical understanding of these enzymes is needed to inform and
diversify strategies to biosynthesize flavonoids that are useful for research. The first aim of this project is to use
an innovative method to measure the mechanisms of FLS1 and F3H. This method will have broad applicability
for studying the mechanisms of other enzymes in the family of alpha ketoglutarate-dependent dioxygenases.
Techniques used to achieve this aim include high resolution mass spectrometry and biosynthesis of isotope
labeled products. The second aim of this project is to elucidate the structures of FLS1 and F3H bound to products
and substrates. Findings from the second aim will help to support the mechanistic findings of the related first
aim. In addition, these findings will provide accurate models for future studies and enzyme engineering
applications, with the goal of diversifying flavonoid biosynthetic strategies. The method used to achieve the
second aim is primarily protein X-ray crystallography. The products of this research will increase our
understanding of the enzyme mechanisms of alpha ketoglutarate-dependent dioxygenases as well as provide
new methods to study them. In addition, new mechanistic and structural knowledge gained about the flavonoid
synthesizing enzymes, FLS1 and F3H, will unlock strategies to create new biosynthetic tools for studying the
effects and fates of their product metabolites, as they relate to human health and disease.

Public health relevance
PROJECT NARRATIVE The goal of this research is to enhance our understanding of the biochemistry of alpha ketoglutarate dependent dioxygenase enzymes by studying Flavanone Synthase 1 (FLS1) and Flavanone 3-Hydroxylase (F3H), which produce the medically significant compounds quercetin and (2S,3R)-trans-taxifolin, respectively. Methods developed through this research will enable future studies on these and the related family of enzymes, many of which are medically important. This research will further support public health by providing accurate enzyme structures to serve as tools to enable the biosynthetic development of specific or novel flavonoids that can be used to study the roles of flavonoids on the microbiome in relation to diseases associated with gut dysbiosis.